Combining immunogenic peptides and Nef blockade to enhance CD8 T-cell-mediated clearance of HIV-infected cells

Project Summary
The expression of the HIV protein Nef during therapy contributes to the persistence of HIV in cells by
downregulating cell-surface major histocompatibility complex type I (MHC-I) and antigen presentation which
allows the virus to evade immune response. Therefore, inhibiting the expression of Nef would allow for MHC-I
expression of HIV antigens on the surface of HIV-infected cells and their clearance by HIV-specific CD8 T cells.
In addition to MHC-I downregulation, there are challenges in developing an effective CD8 cytotoxic T cell (CTL)
response against replication-competent proviruses. The intracellular HIV reservoir becomes dominated by viral
variants containing CTL escape mutations that are resistant to immune response and defective HIV proviruses
can produce viral proteins that act as decoys for CTL response. However, recent studies show polyfunctional
response of CD8 T cells and/or the targeting of T cell epitopes from structurally important (i.e., highly networked)
and genetically-conserved regions of viral proteins are essential for HIV control. In addition, cells harboring T
cell epitope escape mutations can be eliminated by redirecting CD8 T cell response to unmutated viral epitopes
By employing an innovative technique-- an ex vivo HIV eradication assay --using cells from participants
on effective therapy, we expect this exploratory study will reveal that Nef blockade significantly enhances CD8
T cell–mediated elimination of HIV-infected cells containing inducible proviruses. In combination with Nef
blockade, we will augment the clearance of these HIV reservoir cells by expanding HIV-specific CD8 T cells with
a pool of immunogenic peptides that induce polyfunctional/effector CD8 T cell response. These peptides are
selected from topologically important and genetically-conserved regions of six HIV proteins by applying an
immunoinformatics analysis pipeline. Due to the fact these peptides are highly networked within their protein of
origin, they are expected to represent T cell epitopes which lack escape mutations. Therefore, in conducting this
study we will determine the best combination of Nef blockers and immunogenic peptide pools for eliciting CD8
T cell-mediated clearance of HIV-infected cells. This study will accelerate the development of a new HIV
treatment strategy that combines Nef blockade for MHC-I restoration and immunotherapies that elicit effective
CTL response and provide the evidentiary basis for progressing to an in vivo model before this approach can be
applied in a clinical setting.

Public health relevance
PROJECT NARRATIVE HIV persists in a latent form in HIV-infected individuals treated with effective therapy and this latent HIV can rebound when therapy is stopped. However, the elimination of this latent HIV by our immune cells is reduced by the expression of the HIV protein Nef which promotes the survival of HIV-infected cells by decreasing the presentation of HIV-derived protein fragments on the surface of infected cells which are recognized by our immune system. This study will show that the use of potent small molecule Nef inhibitors to reduce Nef expression in combination with immunotherapy will reduce the inducible HIV reservoir in participants on effective therapy bringing us closer to an HIV cure.